Administrative Core

CORE SUMMARY
Core A is the Administrative Core, which provides program investigators, staff, postdoctoral fellows and
graduate students with a central convergence point. This core optimizes program efficiency through execution
of its service and academic components, and by efforts to promote synergy among projects and cores.
Service component: Core A achieves economy of scale and quality assurance through centralized
processing. This core processes manuscripts, letters, reviews, and overnight packages, and it executes
material transfer agreements for both projects and cores. It ensures that labs are compliant with institutional
and federal guidelines for animal care and use, institutional review board (as appropriate), and biosafety. Core
A arranges travel for investigators, and it administers the grant budget in compliance with institutional and
federal regulations.
Academic component: Core A coordinates our weekly research in progress seminar series and the jointly
held Center for Lung Biology and Pulmonary and Critical Care research series. It is also responsible for
organizing program review by internal and external advisors, including site visits. Site visits enable intimate
interaction among program investigators, trainees, and visiting scientists, which significantly influences the
nature and scope of our work.
Synergy with Projects and Scientific Cores: Core A coordinates weekly meetings with project and core
leaders to assess the direction of our work, identify project and core needs, and address areas of synergy
among projects and cores. These regularly held meetings bring investigators together to discuss how we can
most efficiently meet the aims of our individual projects, and also how we can best impact the lung vascular
biology community on the whole.